CMKLR1-Targeted Molecular Imaging of Inflammation as a Precision Medicine Tool in Acute Lung Injury and Fibrotic Lung Diseases

ABSTRACT
Aberrant immune response to injury is a major pathogenic driver of adverse extracellular matrix remodeling after
acute lung injury (ALI) and a wide range of fibrotic lung diseases (referred to inflammation-fibrosis axis).
However, there is currently no established approach for noninvasive assessment of dysregulated lung
inflammation. This gap along with the pathophysiological heterogeneity and variability of the clinical course of
patients has hampered precision medicine management of fibrotic lung diseases. Chemokine-like receptor-1
(CMKLR1) is chemokine receptor which is overexpressed in profibrotic monocyte-derived macrophages, a
leukocyte subset with crucial roles in the pathogenesis of lung fibrosis. Our central goal is to determine the
potential of CMKLR1-targeted PET for i) quantitative imaging of lung inflammation; ii) prognostication of
the risk of disease progression; and iii) early monitoring of the response to anti-inflammatory and anti-
fibrotic interventions in experimental models of ALI and fibrotic lung injury. We will also address the clinical
relevance of CMKLR1-targeted PET and its potential for future clinical translation by determining the expression
of CMKLR1 in the lungs of patients with COVID-19 and several categories of fibrotic lung diseases vs. healthy
controls. Our preliminary data revealed a significant increase in lung uptake of a novel CMKLR1-targeted tracer
(64Cu-NODAGA-CG34) in two murine models of lipopolysaccharide-induced ALI and bleomycin-induced fibrotic
lung injury, which was primarily driven by the accumulation of monocyte-derived macrophages. Our central
hypothesis is that i) CMKLR1 serves as a biomarker of monocyte-derived macrophages in ALI and
fibrotic lung diseases; hence its targeted imaging by 64Cu-NODAGA-CG34 PET allows for ii) predicting
the risk of progression into sustained inflammation and fibrosis; and iii) monitoring the early therapeutic
response to anti-inflammatory and anti-fibrotic interventions. We propose three Specific Aims:
Specific Aim 1: To determine the immunoprofile of CMKLR1-expressing leukocytes in A) murine models of ALI
and fibrotic injury, and B) lung specimens of patients with COVID-19 and fibrotic lung diseases.
Specific Aim 2: To validate the accuracy of CMKLR1-targeted PET as a biomarker of inflammation at different
stages of ALI and fibrotic injury in murine models.
Specific Aim 3: To determine the potential of CMKLR1-targeted PET in A) disease prognostication; and B) early
detection of the therapeutic response in murine models of ALI and fibrotic lung injury.
Impact: By determining the role of CMKLR1-targeted PET for imaging macrophage-driven inflammation and
defining the expression of CMKLR1 across various fibrotic lung diseases, this proposal may lead to a precision
medicine strategy that allows for i) improved risk stratification; ii) prospective identification of patients with a high
likelihood of favorable response to anti-inflammatory/anti-fibrotic interventions (hence, sparing the others from
adverse effects and costs); & iii) personalized treatment adjustment based on early monitoring of the response.

Public health relevance
Project Narrative An aberrant immune response to injury is a crucial pathogenic driver of acute lung injury (clinically known as acute respiratory distress syndrome) and fibrotic lung diseases. However, there is currently no clinical technique for non-invasive assessment of lung inflammation, which has challenged the development of a precision medicine approach to acute respiratory distress syndrome and fibrotic lung diseases. This proposal is aimed to validate the role of targeted imaging of chemokine like receptor-1 (CMKLR1, a relatively recently discovered chemokine receptor contributing to leukocyte recruitment) for quantitative monitoring of lung inflammation, risk stratification of the disease, and monitoring the therapeutic response in experimental models of acute lung injury and fibrotic lung diseases.